UCSF Research in Implementation Science for Equity (RISE)

ABSTRACT/SUMMARY
There is a well-known gap between what we know can optimize health and healthcare and what
happens in everyday practice. Implementation science (ImS) holds promise for generating new
knowledge to close this gap. ImS is especially important for addressing health inequities which
result, in part, from failure to deliver evidence-based practices to marginalized and minoritized
racial and ethnic groups. Implementation science (ImS) is a branch of research that focuses on
the “use of strategies to adopt and integrate evidence-based health interventions and change
practice patterns within specific settings.”1 Appropriate training of junior faculty from
underrepresented minority (URM) backgrounds in ImS may uniquely position them to pursue
innovative research of interest to the National Heart, Lung, and Blood Institute (NHLBI) and to
launch successful careers as independent investigators. The UCSF Research in Implementation
Science for Equity (RISE) program is an innovative research and career development program
grounded in social cognitive career theory that integrates mentoring and targeted social support
with concrete knowledge and skill building. In particular, RISE has provided didactic training,
research experiences, and on-going research mentoring in ImS for URM junior faculty focused on
cardiovascular or pulmonary research, leveraging the considerable expertise in ImS training at
UCSF. These research skills building activities focused on ImS are paired with an innovative
career development program that includes critical activities of importance for this career stage
(including manuscript and grant writing). The training program is led and delivered by successful,
NIH-funded investigators and other outstanding researchers in cardiovascular and pulmonary
diseases at UCSF, and by former RISE scholars. Through this unique combination, RISE and
RISE-2 have provided 75 URM junior faculty with tangible methodological and academic skills to
enhance their own research and compete successfully for NIH resources, while also developing
a strong network of junior faculty conducting research of relevance to the NHLBI. The proposed
RISE-3 builds on the success of RISE and RISE-2 and will add several new components: 1)
expansion of the ImS program curriculum to include content on how to link ImS and health equity
frameworks for designing interventions, collecting data, and assessing outcomes; 2) additional
CIP (Careers in Progress) sessions in the monthly longitudinal curriculum; 3) enhanced
opportunities for peer support, mentoring, and networking, including connecting RISE-3 scholars
to established ImS investigators and to the robust RISE alumni network.

Public health relevance
PROJECT NARRATIVE Implementation science (ImS) is a branch of research that focuses on the “use of strategies to adopt and integrate evidence-based health interventions and change practice patterns within specific settings” and is a major initiative of the NIH research portfolio. There is also greater emphasis on eliminating health inequities and social and structural barriers, such as racism, that fuel health inequities, but no other training programs exist that focus on training junior faculty from under-represented minority (URM) backgrounds in Implementation Science. The UCSF Research in Implementation Science for Equity (RISE) program has successfully bridged that gap for the past 8 years, equipping URM scholars to pursue innovative research of interest to the NHLBI and to launch successful careers as independent investigators.